HEAL Initiative: Integrative Management of chronic Pain and OUD for Whole Recovery (IMPOWR): Research Centers

There is an urgent need to conduct high impact multidisciplinary research for patients with chronic pain
(CP) and opioid use disorder (OUD)in the settings where they receive care and in collaboration with
stakeholders and persons with lived experience (PWLE). We propose to create the Integrative
Management of chronic Pain and OUD for Whole Recovery– Yale and Organizations United (IMPOWR-
YOU). IMPOWR-YOU is a multidisciplinary center led by established investigators with expertise
studying CP and opioid use disorder/misuse (OUD/misuse) and working in partnership with
stakeholders and PWLE. We conduct research in general medical settings (primary care, hospital) and
specialty (opioid treatment programs (OTPs)) with a focus on supporting the career development of
early stage investigators and those from groups traditionally underrepresented in research (URG).
IMPOWR-YOU is comprised of 5 cores (Operations, Stakeholder/PWLE, Career Development and
Diversity, Pilot Projects, Data and Measurement), 2 research projects, and annual Pilot Projects. Our
research, built on previous work of our investigators and stakeholders, addresses critical issues that
face practitioners across the healthcare system. Proposed studies include: 1) In primary care, compare
the effectiveness of a pharmacist led collaborative care approach for patients prescribed long-term
opioids who have CP and OUD/misuse vs. the pharmacist program plus patient referral to a phone-
delivered, cognitive behavior therapy (CBT)-based pain self-management program; 2) In an OTP to
compare the effectiveness of a stepped care multimodal interdisciplinary CP management that includes
CBT, exercise and stress management to treatment as usual in patients receiving methadone or
buprenorphine; 3. In Year 1 conduct a pilot to modify an opioid stewardship program to address the
needs of hospitalized patients with CP and OUD and evaluate its preliminary efficacy. All studies
include outcomes related to pain, OUD, alcohol use, anxiety, depressive symptoms, sleep problems
and some assess stress, stigma and recovery capital. Our Pilot Project Core will oversee the selection
of pilots in Years 2-5 to support early stage investigators and collaborations with stakeholders/PWLE.
IMPOWR-YOU is built on long-standing multidisciplinary research collaborations among diverse
stakeholders, including PWLE, early stage investigators, URG, health systems, and organizations that
produce guidelines for CP and OUD/misuse. IMPOWR-YOU has the ideal mixture of investigators,
including leaders in primary care, addiction medicine/psychiatry, psychology specialty care, clinical
trials, qualitative research and implementation science; established relationships with stakeholders and
PWLE; a track record of innovation, leadership, collaboration, and outstanding productivity to create a
leading Center that will contribute to addressing the unique needs of patients with CP and OUD/misuse.

Public health relevance
PROJECT NARRATIVE: People who have long term pain and are addicted to opioids or who use their prescription opioids differently from how they were prescribed often suffer with their pain and addiction. To create a research center to help this suffering we would bring together researchers from many backgrounds, people who have long term pain and are addicted to opioids, and groups that provide care for these patients to work together. We plan to develop ways to help patients who receive treatment in their doctor’s office, a specialized treatment program and the hospital.